Neoantigen-Targeted Vaccines in Combination with Immune Checkpoint Inhibitors for Pancreatic Cancer

PROJECT SUMMARY
Immune checkpoint inhibitors (ICIs) provide durable clinical responses in about 20% of cancer patients, but
have minimal effects in cancers lacking intra–tumoral T cells. Approaches that turn T–cell–deplete cancers into
ones that attract high–quality T cells are needed to sensitize these unresponsive cancers to ICIs. Tumors contain
somatic mutations that encode for mutant proteins that are tumor–specific and not expressed on normal cells
(termed neoantigens). Cancers, such as melanoma, with the highest mutational burdens are more likely to
respond to single agent ICIs. However, most cancers, including pancreatic ductal adenocarcinoma (PDAC),
have lower mutational loads, resulting in lower antigenicity, weaker endogenous T cell repertoires, and fewer T
cells infiltrating the tumor. PDACs also have an immunosuppressive tumor microenvironment (TME) consisting
of monocytes, B cells and T cells that express T cell inhibitory signals. Preclinical studies show that a mutated
KRAS (mKRAS) vaccine given with ICIs to genetically–engineered mice overexpressing mKRASG12D (KPC mice)
inhibits premalignant lesions from progressing to PDAC (PMID: 24607504). My work with Panc02 cells showed
that a neoantigen–targeted vaccine, PancVAX, a mixture of twelve 20–mer neoantigen peptides, when paired
with IC modulators cleared tumors in Panc02–bearing mice with a survival benefit (PMID: 30333318). In this
proposal we will test the hypothesis that peptide vaccines targeting ‘shared’ mKRAS neoantigens, or
‘personalized’ patient–tumor–specific neoantigens will trigger high–quality neoantigen–specific effector and
effector memory T cells, which will then become available for further activation by ICIs and result in tumor
rejection. We will thus conduct two early clinical trials to test vaccines targeting mKRAS (Specific Aim 1) or
patient–tumor–specific neoantigens (Specific Aim 2) in combination with the ICIs ipilimumab and nivolumab in
patients with resected and metastatic PDAC, respectively. In both instances, we will assess safety of the triple
combinations, perform in–depth immune phenotyping of peripheral blood to include T cell number, quality and
repertoire, and study the cellular architecture of the TME. A complement of state–of–the–art technologies
including single cell RNA–Seq and TCR–Seq, and multispectral immunofluorescence will be utilized. In the long
term, these studies should inform future combination immunotherapy approaches in PDAC patients, and, in the
short term, will provide me with vital new skillsets in bioinformatics, human immunology, and early clinical trial
design. The outstanding mentorship of my Advisory Team, the rich scientific environment at Johns Hopkins, and
the vast array of available resources should poise me to achieve my goal of becoming a funded, independent
investigator in translational oncology by the end of this grant period.

Public health relevance
PROJECT NARRATIVE This proposal focuses on sensitizing pancreatic cancers to immunotherapy by targeting foreign proteins called ‘neoantigens’, which emerge as the cancer grows. Patient’s neoantigens will be identified and targeted by vaccines with a view to trick immune cells to recognize and kill the tumor bearing these neoantigens.